The impact of longitudinal social networks on young adult substance use and misuse

PROJECT SUMMARY / ABSTRACT
Adolescent substance use is one of the strongest predictors of drug overdose and death during adulthood.
However, most individuals who initiate tobacco, alcohol, marijuana, and other drug use do not report
problematic substance use at later points in the life course. To promote healthy substance use trajectories and
prevent the social contagion of substance use, it is necessary to identify key factors that increase young
people’s odds of problematic use in adulthood. In previous research, peer characteristics and relationships
have emerged as important predictors of substance use and misuse in the short term. However, this line of
work has yet to consider how adolescent peer network structures, as well as their stability over time, carry
implications for patterns of substance use and misuse throughout the life course. The proposed research aims
to address this gap by leveraging data from the Promoting School-Community Partnerships to Enhance
Resilience (PROSPER) study. PROSPER is a large longitudinal study that followed individuals from
adolescence to adulthood in rural US communities, a population that remains understudied in substance use
research. Through a data matching initiative with the PROSPER data, the proposed project will develop a
friendship network dataset across a uniquely long period of time from early adolescence to young adulthood.
The resulting linkages will allow for the analysis of new research questions about substance misuse, network
structure, and tie stability during the transition to adulthood. In addition, we will be able to examine how these
relationships vary according to individual demographic characteristics (e.g., gender, sexuality) and the network
processes that define a youth’s school-community context (e.g., the popularity of substance users), which will
be quantified through state-of-the-art statistical methods. We will achieve these goals through two specific
aims. Aim 1 evaluates a theoretical-informed model that examines the extent to which direct adolescent
friendship ties impact substance use and misuse in young adulthood. Aim 2 considers whether young adults
are more likely to report substance use and misuse according to macro-structures of indirect ties and the
broader contexts of their adolescent friendship networks. Across both aims, we will also consider how these
relationships vary according to whether young people maintain or dissolve their adolescent friendships after
leaving high school. Results from these secondary analyses will enhance our understanding of the risk factors
associated with substance use and misuse throughout the life course. Additionally, our findings will help guide
the identification of optimal network targets for future interventions that aim to reduce long-term, problematic
substance use in young adult populations. Informed by our results, prevention programs will be able to
leverage healthy social ties and discourage the formation of high-risk relationships, which will enhance their
ability to prevent future epidemics related to substance use behaviors.

Public health relevance
PROJECT NARRATIVE Adolescence represents a period in the life course when many individuals initiate tobacco, alcohol, marijuana, and other drug use, yet identifying youth who are at risk of experiencing problematic substance use during adulthood remains a challenging task. To improve the long-term success of school-based prevention programs, the current study seeks to expand our understanding of the factors that heighten young people’s risk of using and misusing substances in adulthood by focusing on the relational structures of adolescent peer networks. We evaluate how patterns of direct and indirect friendship ties in adolescence impact adult substance use behaviors and consider whether this relationship varies according to the stability of ties, individual-level characteristics (e.g., gender, sexuality), and school-community context; findings will inform the design of new interventions that leverage existing social ties and discourage the formation of risky relationships to promote long-term desistance from harmful substance use behaviors.